The novel smooth muscle-specific lncRNA CARMN is a critical regulator of smooth muscle phenotype

PROJECT SUMMARY
Phenotypic switching of vascular smooth muscle cells (VSMCs) from a contractile to a proliferative phenotype,
plays a causal role in many human occlusive vascular diseases. However, the key factors critical for the event
are far from completely identified. Emerging evidence suggests that long non-coding RNAs (lncRNAs) are critical
for gene expression but VSMC-specific lncRNAs remain ill-defined. In an effort to identify lncRNAs with a role in
regulating VSMC phenotype, we utilized publicly available RNA-seq and ChIP-seq data sets that are generated
from different cells/tissues to identify VSMC-enriched lncRNAs. This unbiased analysis revealed that the lncRNA
CARMN is specifically expressed in VSMCs. Correlation analysis revealed that SM-specific expression of
CARMN is not only correlated with a set of well-known SM-contractile markers, but also with serum response
factor (SRF) and its cardiac/SM-specific cofactor myocardin (MYOCD). SRF/MYOCD is a transcriptional complex
that plays a critical role in regulating SM-specific contractile gene expression, through binding to the CArG boxes
within these genes. Bioinformatic analysis identified 2 evolutionarily conserved CArG boxes within CARMN gene
locus and our exciting preliminary data further demonstrated that CARMN expression is SRF/MYOCD-
dependent. Furthermore, we found that CARMN is down-regulated during VSMC phenotypic switching in vivo
and in vitro. More importantly, depletion of CARMN inhibits while overexpression of CARMN promotes the
contractile phenotype of VSMCs. Remarkably, our exciting preliminary data further showed that CARMN acts as
a transcriptional activator by binding to MYOCD but also synergistically enhancing MYOCD-mediated
transactivation on SM-specific genes including CARMN itself. Therefore, we hypothesize that SRF/MYOCD
drives SM-specific lncRNA CARMN expression and that CARMN plays a critical role in maintaining the contractile
state of VSMCs through a positive feedback mechanism by binding to MYOCD. Three aims are proposed to test
this novel hypothesis. In Aim 1, we will determine the regulatory mechanism by which CARMN specifically
expresses in VSMCs by using our novel CARMN knock-in reporter mice, ChIP assay, mutagenesis in vitro and
CRISPR-Cas9 genome editing of CArG box in vivo. In Aim 2, we will define the functional role of CARMN in
VSMCs by using our novel inducible SM-specific CARMN KO mice and rat carotid artery balloon injury model.
In Aim 3, we will explore the mechanism of CARMN's action in VSMCs by assessing the physical and functional
binding of CARMN with MYOCD. Completion of these studies will provide novel insights into the mechanisms
controlling VSMC phenotypic plasticity and identify the novel SM-specific lncRNA CARMN for treating many
proliferative vascular diseases.

Public health relevance
PROJECT NARRATIVE Cardiovascular disease is the number one cause of mortality in the US. The proposed study focuses on investigating the function and the underlying mechanisms of the lncRNA CARMN in vascular smooth muscle cells. Identification of the key players in smooth muscle phenotypic modulation will provide the foundation for treating or preventing smooth muscle-related diseases in cardiovascular system.